Leveraging Proteomics to Understand the Link Between Chronic Kidney Disease and Cognitive Impairment

PROJECT SUMMARY
This is the initial submission of a K01 application by Lindsay Miller Ph.D., under the mentorship of Joachim Ix
M.D., at the University of California, San Diego (UCSD). This proposal will establish Dr. Miller as an
independent investigator and will leverage large-scale proteomics to understand the association and predictive
ability of the proteome with cognitive impairment (CI), a clinical symptom of Alzheimer’s Disease and Related
Dementias (ADRD) in older adults with chronic kidney disease (CKD).
Candidate: Dr. Miller’s training objectives and career goals through this proposal include: 1) to become an
expert in CKD and CI in older adults 2) to develop skills in advanced methods for the application to proteomic
data, and 3) to develop skills in grant writing, lab management and career development. Dr. Miller will
accomplish these objectives through mentorship, coursework, and workshops. She has assembled a
multidisciplinary mentorship team comprised of her primary mentor, Dr. Ix, an established leader in nephrology,
and the following co-mentors: Dr. Marquine, an expert in neuropsychology; Dr. Scherzer, the Director of
Biostatistics at the Kidney Health Research Collaboration at the University of California, San Francisco.
Research: CI is a clinical symptom of ADRD, with mild CI being often a precursor to the development of
ADRD. CI is common among patients with CKD; however, CI has received much less investigation than
complications such as CVD and end-stage kidney disease. Studies have primarily used estimated glomerular
filtration rate (eGFR) and urine albumin to creatinine ratio (ACR) to evaluate the relationship between CKD and
CI. However, in recent work the applicant demonstrated that a panel of markers reflecting kidney tubule health
was associated with CI independent of eGFR and ACR in older adults, indicating that these markers of kidney
health do not fully explain its link with CI. Still, the relationship is likely more complex that what can be
identified using a few targeted biomarkers. Thus, Dr. Miller proposes to utilize large-scale proteomic data to
understand the multifactorial relationship between CKD and cognition with the long-term objective that these
insights might lead to novel approaches and therapies to prevent or ameliorate the development of CI in the
CKD population. Next, while large-scale proteomics is optimally suited to understand biological pathways
between CKD and CI, it will not be feasible to utilize in clinical practice to identify individuals at highest risk for
CI. As such, variable selection methods are needed to identify and validate subsets of proteins that will allow
clinical prediction of cognitive impairment. In aim 1, she will identify protein clusters and biological pathways
that associate with CI. This aim will be conducted in 3419 adults with CKD in the Chronic Renal Insufficiency
Cohort Study (CRIC). In aim 2 she will test different penalized variable selection methods to identify a panel of
proteins that predict CI in the same CRIC cohort. In aim 3, Dr. Miller will determine if the clusters and proteins
identified in CRIC externally validate among 1076 older adults with CKD in the Cardiovascular Health Study.

Public health relevance
PROJECT NARRATIVE Cognitive impairment, a clinical symptom of Alzheimer’s Disease and Related Dementias (ADRD) is common among adults living with CKD; however, this condition is understudied compared with other clinical endpoints associated with CKD. Prior work has shown that urine biomarkers of kidney tubule injury and dysfunction are associated with worse cognitive function independent of eGFR and ACR, however, the relationship is likely more complex than what can be identified through a few targeted biomarkers. The objectives of this proposal are to use large-scale proteomics to 1) identify protein clusters and biological pathways that associate with CI among adults with CKD in the Chronic Renal Insufficiency Cohort (CRIC), 2) identify a parsimonious panel of proteins that predict CI by testing penalized variable selection methods in adults with CKD in CRIC, and 3) identify whether aims 1 and 2 externally validate using the Cardiovascular Health Study with the ultimate long- term goal of detecting potential drug targets.